CSHL 2024 Microbiome Conference

MICROBIOME Conference
October 29 – November 2, 2024
The fourth installment of the international Microbiome conference at Cold Spring Harbor
Laboratory will include the latest research exploring the etiology and treatment of a wide-range of
microbe-associated diseases, integrating the disciplines of clinical research, microbiology,
immunology, ecology, bioinformatics and genomics. From the prior meetings in 2019 (inaugural,
in-person), 2020 (virtual due to COVID), 2022 (hybrid), it was clear that the CSHL Microbiome
meeting offers a unique forum where a wide variety of disciplines come together to catalyze new
ideas and integrate approaches focused on the myriad roles microbiomes play in human health.
The explicitly broad definition of microbiomes discussed at this conference will allow for continued
mutual fertilization of ideas, techniques and theories developed by researchers active in clinical,
ecological and evolutionary lines of research. As well as bringing established leaders as speakers,
this meeting will focus on young investigators and trainees to facilitate the scientific interactions
necessary to grow this field and develop novel clinical and experimental approaches, diagnostics
and therapies. The meeting will provide an in-depth focus on both experimental and computational
approaches that are being used to elucidate the mechanisms of microbial community assembly,
inflammatory, immunologic and infectious diseases. We will also explore novel roles for the
microbiome in drug metabolism and response. Microbiome studies that are featured in the oral
presentations will include bacterial, fungal and viral associated disease, and include microbe-
microbe interactions. Oral and poster sessions will focus on major themes of microbiome and the
host response, including Pathogens and Microbial Communities; Using all the Data: Bioinformatic
Analyses; Microbial Molecules and Interactions; Microbes as Machines; Environment and The
Microbiome; Microbial Function, Host Response; Human and Animal Model Studies; Microbial
Ecology and Evolution. The meeting will include two plenary keynote speakers invited to give
longer talks. The oral sessions will begin with two invited talks from established leaders in the
field, followed by 6 shorter talks chosen from submitted abstracts. The inclusion of poster sessions
as well as the allotment of ample time for questions following each talk will encourage extensive
discussion between the participants. The meeting will be small enough (250 - 350 scientists
attending in-person, with an additional virtual audience to broaden access) to facilitate these
interactions, yet large enough to allow for oral presentations from younger investigators and those
with novel perspectives. The integration of a wide variety of aspects of microbiome research will
nucleate new interdisciplinary interactions that will drive this innovative translational field. This
meeting will be distinct in the opportunities for young investigators to present their work and the
coalescence of computational, experimental and clinical disciplines.

Public health relevance
MICROBIOME Conference October 29 – November 2, 2024 PROJECT NARRATIVE Scientific studies have transformed our concept of microbes (bacteria, fungi, viruses, archaea). Whereas we used to conceive of most microbes as disease-causing enemies, we now understand that microbes are essential for promoting health and might also contribute to ameliorating disease. A growing body of research seeks to uncover how microbes interact with each other in multispecies communities and cohabitate with their multicellular human hosts. If we better understand how microbial communities interact, through modeling these interactions and dissecting the mechanisms at this interface, we will open the door to therapies that prevent or correct microbial community dysfunction to promote health and treat disease. The fourth installment of the Microbiome conference will focus on the latest approaches to study and treat the wide-range of microbial associated diseases, integrating the disciplines of clinical research, microbiology, immunology, ecology, bioinformatics and genomics. The integration of a wide variety of disciplines will promote new interactions seldom achieved at other microbiome meetings. This meeting will have a specific focus on young investigators and trainees to facilitate the scientific interactions necessary to grow this field and develop novel clinical and experimental approaches, diagnostics and therapies.